A multivalent O-antigen bioconjugate vaccine for the prevention of Klebsiella pneumoniae infections

PROJECT SUMMARY
Klebsiella pneumoniae is a leading cause of healthcare- and community-associated infections. Moreover,
K. pneumoniae is frequently resistant to last line antibiotics like third generation cephalosporins and
carbapenems. In fact, carbapenem-resistant Klebsiella is considered an Urgent Threat by the CDC requiring
aggressive, immediate action. One of the five core actions proposed by the CDC to combat antibiotic resistance
is for continued investment and development of vaccines to prevent K. pneumoniae as well as other drug
resistant bacterial infections. As such, VaxNewMo developed a multivalent conjugate vaccine targeting the
majority of K. pneumoniae clinical isolates. Conjugate vaccines, composed of a polysaccharide covalently linked
to a carrier protein, are life-saving vaccines used to prevent disease from multiple bacterial pathogens.
Conventionally, conjugate vaccines are manufactured using chemical conjugation, which is notoriously complex,
labor intensive, and imprecise, hindering the development of new conjugate vaccines against existing and
emerging bacterial threats, like K. pneumoniae. Well aware of these drawbacks, VaxNewMo has been advancing
an alternative method for manufacturing conjugate vaccines that utilizes prokaryotic glycosylation systems in a
process termed bioconjugation. VaxNewMo’s proprietary bioconjugation platform relies on a conjugating enzyme
to transfer a bacterial polysaccharide to a carrier protein all within the lab safe bacterium E. coli. Moreover, since
bioconjugation is an enzyme driven process, the conjugates produced are non-derivatized and are therefore
structurally identical to those presented to immune cells by the pathogen itself. Bioconjugation can be used to
rapidly produce many conjugates simply by introducing new genetic information encoding for a different
polysaccharide serotype into a bioconjugation competent strain of E. coli. As an example of this, we developed
a multivalent O-antigen bioconjugate vaccine targeting >80% of K. pneumoniae isolates encountered in the clinic.
In this Fast-Track application, we will validate the vaccine for immunogenicity and subsequently determine
optimized doses in mice and rabbits, assess functional antibody responses as well as vaccine efficacy by
performing challenge studies. In Phase I, we will assess immunogenicity of monovalent and multivalent O-
antigen bioconjugate formulations by performing dose-escalation studies in mice. Immunogenicity will be
assessed by ELISA for serotype-specific total IgG and IgG subtype antibody concentrations pre- and post-
immunizations to each O-antigen formulated into the vaccine. Once validated for immunogenicity, we will
proceed to Phase II. In Phase II, we will produce the vaccine in larger batches using a scalable microbial
bioreactor system. Subsequently, we will assess functional antibody responses via a serum bactericidal assay
(SBA) and an opsonophagocytic killing assay (OPKA) as well as perform challenge studies in mice vaccinated
with a mouse optimized dose of the multivalent O-antigen bioconjugate vaccine. Finally, we will confirm
immunogenicity and functional antibody responses (SBA and OPKA) of monovalent and multivalent O-antigen
bioconjugate formulations in rabbits, a widely utilized animal model for conjugate vaccine development.

Public health relevance
PROJECT NARRATIVE The goal of the project is to accelerate preclinical development of a vaccine for the prevention of Klebsiella pneumoniae infections. We have developed a vaccine targeting more than 80% of K. pneumoniae isolates encountered in the clinic and seek to validate its ability to elicit a protective immune response.